Identifying and testing new targets for Parkinson Disease gene therapy

DESCRIPTION (provided by applicant): One of the key problems in Parkinson Disease (PD) genetics is that mouse transgenic models have often not recapitulated what is seen in humans. Although Drosophila and yeast models have been useful, they do not have the unique architecture of the nigrostriatal tract that control the symptoms seen in PD. Our group has pioneered the use of recombinant Adeno-associated virus (AAV) as a gene transfer vehicle to the brain, which we believe is a valuable adjunct to conventional mouse transgenics. Using this method we can bypass many of the problems encountered in mouse transgenic systems, including embryonic lethality and developmental adaptation. In work already published, we showed that expression of human α synuclein (α syn) in the rat substantia nigra causes reproducible and progressive neurodegeneration of the nitgrolstriatal tract, loss of dopamine, and behavioral abnormalities that are typical to PD. One of the key advantages of this approach is that the same construct used to study a genetic question in rat brains can be used in primates as well. This genetic transfer system is unique in that gene dosage can be manipulated and gene expression is permanent. In this application, we use this technology to focus on an important question in PD: What is the function of α synuclein? Our preliminary data demonstrate four novel things. First, that modest (2 fold) overexpression of phospholipase D2 (PLD2) in the SNc causes acute and severe neuropathology. Second, that α syn is an inhibitor of PLD2 pathology. Third, that we see the same type of neurodegeneration when we knock down α syn with siRNA as we see with overexpression of PLD2. And fourth, that phosphorylation of α syn at the ser 129 position controls its ability to inhibit PLD2 in vivo just as it does in vitro. Taken together, this demonstrates that at least one important function of 1 syn is to modulate the activity of PLD2. This had been anticipated by several groups based on in vitro and cell culture experiments, but had not been shown previously in an in vivo system. Moreover, our data also shows for the first time that α syn is an essential protein, at least in the SNc. This runs counter to what had previously been seen with mouse α syn knockouts and highlights the potential usefulness of this alternative genetic approach to studying Parkinson Disease. However, the most important aspect of this work is that we have potentially identified several new therapeutic targets for treating PD, including PLD2 and the kinase(s) that phosphorylate 1 syn. It is also now possible to tease out the mechanism of the PLD2/?? syn interaction that leads to neurodegeneration and this will hopefully identify additional therapeutic targets. The proposal has three specific aims: 1) To use PLD2 mutants to determine which of the PLD2 functional domains is responsible for PLD2 toxcity, its catalytic domain or its protein interaction domains, 2) To identify the kinase that phosphorylates α syn in vivo, 3) To test the possibility that PLD2 function affects D2 dopamine receptor activity, which is a key dopamine cell regulator.

Public health relevance
PUBLIC HEALTH RELEVANCE: We have discovered that expression of PLD2 in the rat substantia nigra also causes a Parkinson like neurodegeneration, and that coexpression of α synuclein suppresses PLD2 toxicity. This suggests that misregulation of PLD2 may be the initial cause of Parkinson Disease. Our proposal describes experiments designed to identify the downstream mediators of PLD2 toxicity and the kinase that phosphorylates S129 in vivo, and this will hopefully provide new targets for Parkinson Disease gene therapy which we will test in the rat model. We have discovered that expression of PLD2 in the rat substantia nigra also causes a Parkinson like neurodegeneration, and that coexpression of α synuclein suppresses PLD2 toxicity. This suggests that misregulation of PLD2 may be the initial cause of Parkinson Disease. Our proposal describes experiments designed to identify the downstream mediators of PLD2 toxicity and the kinase that phosphorylates S129 in vivo, and this will hopefully provide new targets for Parkinson Disease gene therapy which we will test in the rat model. __SpecificAimsTextDelimiter__ Specific Aims We and our collaborators have developed an easy and reproducible way of using recombinant Adeno- associated virus (rAAV) to express genes specifically in the rat substantia nigra pars compacta (SNc). We used this technique to demonstrate that expression of human wild type and mutant α synuclein (α syn) produced significant and consistent neurodegeneration in the rat that was similar to that seen in Parkinson Disease (PD). More recently, we have shown that a mutant of α syn that mimics phosphorylation at position S129 (S129D) is significantly less toxic than its phosphorylation negative counterpart, S129A. Although it is generally believed that a syn aggregation, possibly in concert with oxidative stress, is the precipitating cause of nigral neurodegeneration, the physiological role of α syn in the substantia nigra is not known. α syn has been shown to be a potent inhibitor of Phospholipase D2 (PLD2) in vitro. PLD2 cleaves phosphatidylcholine to produce phosphatidic acid (PA), a molecule that is important as a signaling molecule, as a membrane anchor for a variety of signal transduction proteins, and finally, as a mechanism for promoting vesicle budding and vesicle-membrane fusion. Like α syn, PLD has been implicated in both vesicle trafficking at the Golgi and at the membrane. Recently, we obtained evidence that over expression of PLD2 in the rat SNc causes rapid and severe neurodegeneration. Wild type α syn largely suppressed PLD2 toxicity but the S129D mutant of α syn, which had been shown to be defective for PLD2 inhibition in vitro, did not suppress PLD2 pathology in vivo. Consistent with this, we find that knockdown of the endogenous rat α syn causes the same acute toxicity seen with overexpression of PLD2. Moreover, knock down of PLD2 activity by a PLD2 directed siRNA produced an unusual contralateral rotation that was similar to that seen when α syn is overexpressed. Our observations suggest that α syn may initiate neural toxicity through aberrant control of PLD2, and that this may be an early precipitating event in neurotoxicity. In addition, a likely target for PLD2 may be the D2 dopamine receptor. This raises the possibility of identifying additional targets for treating Parkinson Disease. We propose in vivo experiments to determine the most likely mechanism of PLD2 toxicity. We will also identify the kinase that functions in vivo to phosphorylate α syn S129, which appears to be a key event in both PLD2 regulation and neurotoxcicity. The goal is to identify and validate new genes for gene therapy intervention for Parkinson Disease. Our aims are: 1) To use mutants of PLD2 and biochemical assays in the rat model to identify the mechanism of PLD2 induced neurodegeneration of SNc. PLD2 has been implicated in a number of cellular processes and mutants of PLD2 have been identified that target the various functions. We will use these mutants to determine if one of the PLD2 pathways that has already been identified through known mutations is responsible for neurodegeneration. 2) To use the rat model of PD to identify the cellular kinase(s) that phosphorylates α syn on ser129. Based on current in vitro information, we anticipate that the kinase will be one of the GRKs or casein kinase 1 or 2. We will also test the possibility of upregulating expression of the relevant kinase using gene transfer as a method for suppressing wt a syn toxicity. 3) To test the possibility that PLD2/α syn interaction with the D2 dopamine receptor is responsible for the PLD2 phenotype and to test the possibility that the α syn/PLD2 interaction modifies DA release.